Durability and mechanisms of dengue vaccine and infection mediated immunity

Dengue virus (DV) is a global pandemic causing 400 million infections annually; many veterans are exposed to
dengue while serving in endemic areas. There are 4 co-circulating viruses, severe disease is most commonly
seen with 2nd infections and caused by low-titer antibodies from first infection mediating enhanced
viremia/disease on 2nd infection (ADE). To date there are no therapies or vaccines safe in all people, however
TDV/TAK003, a live attenuated tetravalent vaccine, has shown good safety and protection up to 4.5 years post
vaccination, and just received its first approval. This is the first dengue vaccine safe and protective in a DV
seronegative population. TDV/TAK003 induces type-specific neutralizing antibodies to DV2, and mostly cross-
reactive antibodies to DV1,3, and 4. TDV/TAK003 includes CD4+ and CD8+ T cell epitopes, unlike the earlier
Dengvaxia, which caused increased disease in DV seronegatives, did not. We have shown that TDV/TAK003
induces durable type-specific CD4+ and C8+ T cell responses, still detectable 10 years post vaccination, while
a single natural infection does not. Further, TDV/TAK003 induces multifunctional cytotoxic CD4+ T cells,
which are not seen after first infection but are seen after 2nd infection, per our data and reported by others. We
hypothesize that TDV/TAK003 induces a durable immune phenotype comparable to immunity after 2 DV
infections, the current best model of protection in humans. Since TDV/TAK003 may receive wide approval in
the next year, it is vital to better understand the type, specificity, and durability of post vaccination immunity in
seronegatives and how this compares with seropositive vaccinees (who have stronger and broader protection)
and immunity after 2nd infection. Durability of immunity is key after vaccination, especially in dengue, given the
risk of severe disease as immunity wanes. We have an ongoing study with multiple stored serum and PBMC
samples from TDV/TAK003 vaccinees and infected veterans, and collaborators in Puerto Rico and Colombia
will provide us with samples from seropositive vaccinees and people with post 2nd infection immunity. We
hypothesize that durable protective immunity after TDV/TAK003 vaccination in seropositives and
seronegatives is mediated by multiple mechanisms, including durable type-specific polyfunctional CD4+
cytotoxic T cells (CTLs), memory B cell secreted antibodies (MBCs) and Fc-mediated antibody cytotoxicity
(ADCC) in addition to better studied type-specific neutralizing antibodies. We hypothesize that vaccine
immunity is broader and more sustained than immunity after 1st DV infection, and closer to immunity after 2nd
infection. We hypothesize that TDV/TAK003 immunity is durable and protects from DV disease in an adoptive
transfer murine model up to 10 years after vaccination. To challenge our hypotheses, we will
Aim 1: Determine the specificity and functionality of durable B cell immunity in seronegative and seropositive
TDV/TAK003 vaccinees compared with people recovered from 1st and 2nd DV infections.
Aim 2: Determine if multifunctional type-specific CD4+ CTLs seen after 2nd infections (thus associated with
protection) are uniquely induced by vaccination and 2nd but not 1st infection, and kill DV+ target cells.
Aim 3: Determine if durable seronegative immunity after TDV/TAK003 vaccination inhibits DV
replication/disease in an adoptive transfer murine model, and if this inhibition is comparable in strength and
breadth to seropositive TDV/TAK003 vaccinees and 2nd infections.

Public health relevance
Dengue disease is a global health emergency with half the world’s population at risk. Hundreds of veterans were hospitalized with dengue in Florida and Puerto Rico in a recent outbreak. There are 4 dengue viruses, infection with a 2nd virus 2+ years after the first infection has the highest risk for severe disease. Many recent deployments including to Somalia, Iraq, and Afghanistan were in dengue endemic areas; veterans who served in these areas are potentially at risk for severe dengue disease if exposed again. A dengue vaccine, TDV/TAK003, has recently shown good safety and protection in 4.5 years of followup. However the mechanisms of protection are not yet fully understood. Using samples already collected from vaccinees and U.S. veterans as part of our ongoing study, and collaborations which will provide us with samples from people who have had multiple dengue infections and are therefore protected, we will define the durability of immunity provided by the TDV/TAK003 vaccine. We will determine the specificity and durability of antibodies, memory B cells, and other potentially protective antibody mediated functions. We will determine if a recently described T cell phenotype is able to kill dengue infected cells in the lab. Finally, we will use a mouse model to determine if immune cells and antibodies can mediate durable protection in a mouse model. There studies will improve understanding of how this vaccine mediates protection, which is significant as TDV/TAK003 could soon be approved for use in the U.S.